Integrated Genomics Core

INTEGRATED GENOMICS CORE | PROJECT SUMMARY
The aim of the CLEAR Consortium’s Integrated Genomics Core is to facilitate synergy
between the different projects and accelerate the program by providing a comprehensive, cost
effective and highly integrated suite of genomic services used by all three Projects. Project 1
performs genome/exom sequencing of patient-parent trios to identify putative TED-causing
variants, and has established the CLEAR registry a database that integrates genomic and
clinical data. Projects 2 and 3 will perform experiments with single cells RNA-seq and ChIP-seq
analyses to define the genomic basis of normal and disrupted TE development in animal models
and human iPSC-derived organoids. The Core will used state-of-the-art bioinformatics,
computational and statistical methods to analyze and integrate of all this genomic data. The
core provides statistical rigor, supports bioinformatics literacy of the wet bench teams, provides
data management, and facilitates data sharing between the projects and broader scientific
community.